Administrative Core

The Administrative core will be responsible forthe overall management, communication, coordination and supervision of the grant. The Core will coordinate interaction between the 5 Study Sites, the Project P.l.s and Core directors. The Administrative Core will facilitate progress and completion of individual projects. The Core will schedule investigator meetings and conference calls, produce a quarteriy report to keep sites abreast ofthe progress ofthe studies, report to the NIH Steering Committee (and Core personnel will attend Steering Committee meetings), and ultimately assist in manuscript preparation, research reports and correspondence for investigators. The grant requires specimen and clinical data collection at the sites, transmission ofthe specimens to the central labs, and transmission of the clinical data to the multicenter database. The Core will facilitate seamless interaction between sites. Project, and Core personnel. The Core will be responsible for the disbursement of funds and for the preparation of the annual progress reports for the NIH.

Public health relevance
RELEVANCE (See instructions): Our grant consists of 5 Study Sites, 3 Cores, and 2 Projects. The Administrative Core will facilitate progress toward our goals: to determine if genetic variation is associated with kidney transplant outcome and /or immunosuppressive drug disposition and toxicity. Our findings may lead to the ability to individualize immunosuppressive therapy based on genetics to improve recipient outcome, and may elicit new information on pathways important in the immune response or in immunosuppressive drug efficacy, disposition, and toxicity.